Nicotinamide nucleotide transhydrogenase and bioenergetic metabolism in complex I defective cardiac mitochondria

More than 1 in 5000 children are born with inherited mitochondrial diseases from which 30-40% are complex I
(CI) defects that lead to cardiomyopathy, heart failure and death. A large proportion of chronic conditions
(diabetes, coronary artery disease, heart failure, aging) develop mitochondrial CI defects that are key factors
promoting disease progression and cardiac complications. Pathogenic mechanisms that link CI defect with
heart disease include energy deficit, oxidative stress, and an increased [NADH]. Either inherited or acquired,
mitochondrial CI defects have no cure. We propose a novel therapeutic target that preserves cardiac oxidative
metabolism and function in mitochondrial cardiomyopathies. The objective of this project is to determine if the
mitochondrial enzyme, nicotinamide nucleotide transhydrogenase (NNT), is necessary to sustain cardiac fatty
acid (FA) β-oxidation for ATP production under conditions of reductive stress (increased NADH) caused by a
mitochondrial CI defect. We hypothesize that NADH accumulation induced by a CI defect decreases cardiac
oxidative metabolism thus decreasing FA oxidation and ATP generation, and inducing oxidative stress. An
intact NNT provides an alternate route to consume the excessive NADH and form FADH2 to maintain FA
oxidation and prevent oxidative stress and ATP depletion while preserving cardiac function. First specific aim is
to determine if NNT is necessary to protect the heart function and structure in mitochondrial CI defect. The
second specific aim is to delineate the role of NNT in sustaining complete FA β-oxidation and ATP production
in CI defective mitochondria. The third specific aim is to decipher the contribution of NNT to normalize redox
status and decrease oxidative stress in CI defective mitochondria. Our specific objective aligns with the goal of
our research to cure mitochondrial cardiomyopathies. We will compare hearts, cardiomyocytes and
mitochondria from mice with normal and absent (systemic and cardiac specific) CRISPR NNT knockout on the
C57BL6N background. Rotenone-induced and human-like NDUFS4-deficient cardiac specific CI defects will be
used. Expected outcomes will determine if NNT is a potential therapeutic target to preserve cardiac oxidative
metabolism and function in mitochondrial cardiomyopathy.

Public health relevance
At least one in 5000 individuals are born with inherited mitochondrial diseases from which 30- 40% are complex I defects that lead to cardiomyopathy, heart failure and death. A large proportion of chronic conditions (diabetes, coronary artery disease, heart failure, aging) develop mitochondrial complex I defects that are key factors promoting disease progression and cardiac complications. Either inherited or acquired, mitochondrial complex I defects have no cure. We propose that the mitochondrial enzyme, nicotinamide nucleotide transhydrogenase, is a novel therapeutic target that preserves cardiac oxidative metabolism and function and alleviates mitochondrial cardiomyopathies.